ANTI CD45 MAB IN LEUKEMIA PRIOR TO STEM CELL TRANSPLANTS

Stem cell transplantation can be relied upon to salvage some patients with recurrent or resistant leukemia, but many others continue to succumb to resurgent disease. Studies outlined in this proposal will test a combination of two anti-CD45 monoclonal antibodies (Mab) for its safety, biologic activity and pharmacokinetic properties in patients with relapsed acute leukemia and CD45 + blast cells who are to receive allogeneic stem cell grafts. Dose escalations, from 6.25 to 6400 mg/kg, will permit identification of a maximum tolerated dose (MTD) as will as the dose that produces discernible biologic effects in patients. The underlying hypothesis of this research is that the MAb combination will have antileukemic activity and will enhance engraftment, without the toxicity associated with standard conditioning regimens. Thus, studies are planned to determine the effects of anti-CD45 MAb dose escalations on normal hematopoiesis and lymphopoiesis, leukemia blast cells and myeloid/platelet engraftment times, as compared with historic controls not receiving the antibodies. By the end of this 2-year study, the safety of the anti-CD45 MAb combination will be established, as will its effects on normal and malignant lympho-hemopoietic cells in vivo. Because the MAb to be tested rely on host effector mechanism rather than conjugated toxins or radionuclides, demonstration of significant biologic activity will indicate the potential of these MAb as stem cell transplant-conditioning agents. In fact, depending on the outcome of the studies proposed, they might well be used as the sole conditioning agent in patients who are to receive allogeneic transplants for nonmalignant disease, or gene modified autologous stem cell.